Squirrel Monkey Breeding and Research Resource – Administrative Supplement (Brain and Genomic Resource Development)

Project Summary
Alzheimer’s disease (AD) is a major health concern defined by pathologic changes in the brain that
coincide with altered behavior and cognitive function. Many have suggested that there is a need for primate
models of AD because they naturally recapitulate some neuropathological features of AD with advanced age
whereas other model organisms do not (i.e., rodents). For instance, while amyloid-beta (Aβ) deposition occurs
in most mammals, tau-positive neurofibrillary tangles (NFT) have only been identified in a few nonhuman
species studied to date. Additionally, elderly nonhuman primates, develop cerebral amyloid angiopathy (CAA),
a neurovascular condition found in 80% of AD patients and associated with cognitive decline. Here, we are
requesting supplemental funding to further develop the squirrel monkey model for use in research on cognitive
aging and the development of CAA and related AD pathology. In Aim 1, we propose to perform whole genome
sequencing (WGS) in a sample of 140 squirrel monkeys. The selection of animals will be based on two factors:
a) previous knowledge that individuals are descendants of animals with known AD-related phenotypes, and b)
efforts to maximize the future utility of the information obtained by sequencing breeding animals that are
producing the next generations of colony animals. The WGS data will be made publicly available to the
scientific community and will used to perform preliminary analyses of association with cognitive phenotypes
and biomarkers currently being obtained in this same cohort of monkeys. In Aim 2, we propose to
prospectively develop a systematic collection program to obtain frozen and fixed brain materials form the
squirrel monkey population. This program will be modeled after existing postmortem brain programs and will
allow for harmonization in the curation and storage methods across multiple species used in comparative
studies of aging and AD pathology.

Public health relevance
Projective Narrative Alzheimer’s disease (AD) and age-associated neurodegenerative disorders are a major public health concern. The proposed studies aim to further develop squirrel monkeys as a model species for studies on cognitive aging and their potential associations with neurological and pathological changes in the central nervous system. Further development of primate models for studies on AD pathology and related dementias will provide new and alternative avenues of therapeutic interventions with increased translational value compared to other model species.